The Effect of Cytomegalovirus Infection on Daily Stress Processes in Early Adulthood

Stress is acutely beneficial for survival but can increase risk for chronic disease development across the
lifespan. Understanding the biological mechanisms that increase vulnerability to experience more stressors, or
react more negatively to them, can identify who is at risk for negative health outcomes associated with stress,
and assist targeted prevention and mitigation efforts aimed at improving well-being, increasing years of healthy
living, and decreasing healthcare burden through aging. A positive feedback loop, called the Immunologic
Model of Self-Regulatory Failure (Shields et al., 2017), provides one potential framework for studying biological
and physiological vulnerabilities to daily stress: increased physiological activation leads to neurological
dysfunction, which leads to subsequent self-regulatory deficits and increased experiences of future stressors,
and the cycle repeats. This model suggests that increased immune activation, dysregulation, or neurological
changes may increase vulnerability to stress by way of self-regulatory deficits. Cytomegalovirus (CMV), an
asymptomatic, latent herpesvirus is one such immunological factor that may increase vulnerability to stress
and its effects. CMV is associated with faster immune system aging and heightened systemic inflammatory
biomarkers in older age but may affect health, and increase vulnerability to stress, earlier in life. Importantly,
neurological regions affected by CMV coordinate higher-order psychological abilities, such as planning,
inhibiting, and regulating oneself, called self-regulation. In older adults, CMV seropositivity is associated with
declines in self-regulation, assessed via self-report, but this has yet to be tested in younger adults (Segerstrom
et al., 2022). Further, individuals with poor self-regulation may experience more stressors (e.g., relationship
problems, debt, etc.) and be more reactive to them (e.g., report a more intense, negative mood following a
stressor) compared to someone with better self-regulation. Though studies on self-regulation and stress, the
effects of CMV at older ages, and preliminary investigations on CMV and stress have been conducted, little is
known about biological mechanisms linking CMV, self-regulation, and daily stress in younger populations who
may still be able to modify or prevent CMV-related interference on daily life and future health. The proposed
project aims to fill these gaps by evaluating the relationships between CMV infection, daily stress, and self-
regulatory abilities. The research component of this proposal involves a single in-person laboratory visit for
questionnaires and dried blood spot collection and a 14-day daily diary to test (a) how CMV is related to daily
stress processes in early adulthood and (b) the mechanisms that may explain these associations. The training
component of this proposal includes (1) training, collection, and analysis of biological specimen, (2) primary
data collection from an undergraduate sample, (3) advanced training in statistical methodology and R
programming, (4) advanced training and expertise building in psychoneuroimmunology, and (5) extensive
professional development and ethics training in preparation of a competitive academic career.

Public health relevance
Stress is beneficial for survival in the short-term but can negatively affect long-term health and mortality when endured chronically. The proposed project will investigate Cytomegalovirus, an asymptomatic, latent herpesvirus, as an immunological factor that may increase vulnerability to experience more daily stressors, and react more negatively to those stressors, in young adults by way of deficits in self-regulatory abilities, such as emotion regulation, self-control, and inhibition. Understanding the biological mechanisms that increase vulnerability to stress, can identify who is at later risk for negative health outcomes associated with stress, and assist future, targeted prevention and mitigation efforts aimed at improving well-being, increasing years of healthy living, and decreasing healthcare burden during aging.